Central nervous system mechanisms and treatment response in chronic ocular surface pain

ABSTRACT
Chronic ocular surface pain (COSP) affects approximately 5-15% of the US population at some time in their lives
at an estimated cost of over $55 billion annually. People with COSP experience painful eye burning, irritation,
and aching, leading to functional impairment and decreased quality of life. Conventional treatments directed at
the ocular surface – the perceived pain source – are inadequate for pain relief in over 50% of patients. We
hypothesize that some individuals with COSP also suffer symptoms driven by central nervous system (CNS)
dysfunction, similar to chronic overlapping pain conditions, rather than solely pathological problems in the eye.
These chronic overlapping pain conditions (e.g., fibromyalgia or interstitial cystitis/bladder pain syndrome) show
clear nociplastic mechanisms, where the pain results from amplified and/or dysregulated CNS signaling and
sensory processing. Our premise is supported by nociplastic pain features observed in COSP. These include:
(a) pain with minimal ocular surface signs (sign/symptom discordance), (b) multisite pain and CNS-mediated
somatic symptoms (fatigue), (d) augmented CNS pain processing on evoked sensory testing and neuroimaging,
and (e) persistent pain after topical anesthetic. To date, no comprehensive study has investigated the clinical,
neurobiological, and treatment response features of nociplastic pain in a cohort of COSP sufferers. We will
rigorously define the role of nociplastic pain in COSP with a large, representative cohort of patients (N=200)
using established clinical phenotypic, neurobiological, and treatment response features. We propose that as
sign/symptom discordance increases so will features indicative of nociplastic pain. In Aim 1, we will clinically
phenotype COSP participants using validated patient-reported outcome measures and ocular exams. In Aim 2,
we will compare the neurobiological features of nociplastic pain across the discordance spectrum among a
subset of Aim 1 participants. For this intensive examination subset, we will use multimodal evoked sensory
testing and structural/functional brain MRI to assess regions important for pain perception and modulation.
Similarly, we hypothesize that patients with high pain discordance will exhibit amplified multisensory perception
and increased pro-nociceptive functional connectivity. In Aim 3, we will examine and validate predictors of
COSP pain responses before and after application of a topical anesthetic to the ocular surface. The use of
topical anesthetic should block peripherally induced discomfort to allow for clarification of pain origination. We
hypothesize that patients with heightened nociplastic pain features will have reduced anesthetic response.
Findings from the study have the potential to fundamentally change the way ocular pain syndromes are
conceptualized, diagnosed, and treated. The work is likely to identify new integrative CNS-directed pain
treatments for patients with COSP and will provide fundamental insights into the ineffectiveness of peripherally
directed therapies.

Public health relevance
Chronic ocular surface pain is common, disabling, costly and treatments directed at the ocular surface are often ineffective. Instead, the source of pain maybe dysfunction of pain signaling and processing in the central nervous system similar to other chronic pain conditions, such as fibromyalgia. Our study seeks to define the role of central nervous system dysfunction in chronic ocular surface pain to impact diagnoses and treatments.